Integration of Olfactory and Visual Stimuli for Navigation in Drosophila

PROJECT SUMMARY/ABSTRACT
Animals respond to changes in their external environment and promote pro-survival behavioral output. Shifts in
an animal’s internal state, or a shift neuronal processing mediated through neuromodulation, drive these adaptive
behavioral responses, affecting sensory and memory processing. State-dependent modulation can be harmful
when it is related to drugs of abuse, particularly alcohol. This project aims to understand the mechanisms and
circuit motifs that mediate state-dependent modulation of alcohol memory circuits. Understanding these circuit
mechanisms will highlight how internal state, brought about by stress, mood, and physiological state, can affect
drug abuse disorders, cravings, and relapse. Briefly, Drosophila melanogaster were conditioned with a spaced-
training paradigm to associate an odor cue with an intoxicating dose of alcohol, and preference was tested the
following day. Octopaminergic neurons, the invertebrate equivalent norepinephrine, were found to modulate
olfactory reward memory circuits necessary for alcohol memory acquisition and retrieval in fruit flies.
Thermogenetic inhibition of octopaminergic neurons showed that modulation occurred only when flies were in a
food-deprived state, and this neuromodulation was necessary for the acquisition and retrieval of the alcohol
memory. In-vivo calcium imaging will be used to assess the activity of the subset of octopamine neurons
mediating this state-dependent modulation (satiated versus food-deprived states) and their downstream post-
synaptic partners. Neuronal activity of the identified state-dependent octopaminergic circuit will be assessed
during intoxication, naïve odor exposure, odor-alcohol pairings, and paired- or unpaired-odor re-cue. These
experiments will highlight state-dependent mechanisms for memory processing, by which shifts in internal state
can affect the acquisition and retrieval of memories related to drugs of abuse. The applicant will acquire training
in calcium imaging and sophisticated data-analysis methods to follow-through on these experiments, with
ongoing professional development training to help develop the applicant for the next stage of their career as a
postdoctoral researcher. The applicant will continue to pursue mechanisms of state-dependent modulation and
how that affects multi-sensory integration, to drive behavioral choices. In the postdoctoral phase, the applicant
will gain proficiency in calcium imaging techniques, computational skills, and continued training in analytical
methods to examine large-scale calcium imaging data sets. Additionally, the applicant will further their
professional development and grow towards becoming an independent researcher at an academic institution.

Public health relevance
PROJECT NARRATIVE The proposed research will contribute to the fundamental knowledge of how neural circuits can undergo modulation to drive adaptive behavioral responses to account for changes in their external environment. My work focuses on how these shifts in neuromodulation can affect memory processing circuits and lead to changes in the acquisition and retrieval of memories. This becomes particularly important when it comes to drugs of abuse, specifically alcohol, and my work will highlight mechanisms by which an animal’s internal state can affect memory processing for drugs of abuse.